Mechanisms of granulocyte homeostasis

PROJECT SUMMARY/ABSTRACT
A fundamental challenge in developmental biology is delineating hierarchical cellular states including rare
intermediates and their underlying gene regulatory networks that mediate cell-type specification. Previously, we
utilized scRNA-Seq, developed novel bioinformatics approaches and clonogenic assays to delineate
hierarchical genomic and regulatory states culminating in neutrophil or macrophage specification. Our analysis
captured prevalent mixed-lineage intermediates (MultiLin*) that manifested coincident expression of
hematopoietic stem cell/progenitor (HSPC) and myeloid progenitor genes. Here, we used primary mouse bone
marrow progenitors to: 1) rigorously identify stable developmental cell states and rare intermediates, 2)
overcome major informatics hurdles to integrate multiomic data sets with flow cytometry to validate
hypotheses, and 3) link neural-network-identified TF activity on chromatin to dynamic gene expression;
predicting hematopoietic TF cistromes. Our Preliminary Data reveals nascent transcription factor programming
within the MultiLin that restricts lineage potentials, yet precurses bipotential progenitors and lineage
specification and commitment. We hypothesize that within the homeostatic hematopoietic system, successive
myeloid lineage restriction events begin within MultiLin. The proposed work will isolate cluster-defined cell
populations and define their developmental potentials, establish a validated network to establish the
combinatorial regulatory TFs that program hemopoietic progenitors, then exploit this network to define the
genomic and cellular impact of emergency stress adaptations which stimulate erythroid and neutrophil
granulocyte production.

Public health relevance
PROJECT NARRATIVE The proposed work exploits single-cell analytics to characterize the molecular signature of the homeostatic state of hematopoiesis that sustains health and wellness. Specifically, it will generate gene regulatory networks for hematopoietic progenitors, which integrate the activity of transcription factors (TFs), enhancers and chromatin to reveal a blueprint underlying those patterns, and illustrating the drivers of developmental cell fate decisions.